Administrative Core

The Administrative (Admin) Core of the Penn INSPIRE Center will lead senior and emerging investigators in
establishing, implementing, and evaluating a cutting-edge, interdisciplinary scientific agenda that leverages
implementation science to optimize suicide prevention for underserved populations. Based at the Penn
Perelman School of Medicine, INSPIRE will have interdisciplinary collaborations from the Penn Center for
Clinical Epidemiology and Biostatistics, Children’s Hospital of Philadelphia, and the Penn School of Nursing.
INSPIRE will integrate perspectives from psychology, implementation science, psychiatry, machine learning,
health economics, and health information technology. Realizing the benefit of such a rich, interdisciplinary
research endeavor requires strong and creative centralized leadership as well as efficient and effective
coordination of services, logistics, and resources. Led by Center Co-Directors G. Brown and Oquendo, the
Admin Core will be INSPIRE’s organizational, governance, and strategic-planning hub and will address three
Aims. First, the Core will provide scientific and programmatic leadership to maximize integration, rigor, and
synergy across Center components, investigators, and external affiliates. It will institute and coordinate an
internal Center Steering Committee and Stakeholder Committee and an External Advisory Committee for
transparency and input on governance, planning, and evaluation. Centralized administrative, fiscal, and
organizational coordination of INSPIRE Cores and Research Projects will be effected by an experienced,
efficient Administrative Support Team. Second, the Admin Core will ensure scientific innovation and
responsiveness to evolving research, practice, and policy needs through the INSPIRE Pilot Studies Program
that will support 10 pilot studies over the course of the Center. The Core also will establish the INSPIRE
Suicide Prevention Scholars Program to engage and build capacity of both early-stage and established
investigators who can make novel interdisciplinary contributions to the suicide prevention research evidence
base. Third, the Admin Core will amplify the impact of our research and make INSPIRE resources available
across scientific, practice, and policy communities through a dynamic INSPIRE website as well as other
targeted mechanisms for wide, multi-sector dissemination of Center findings, research tools, and other
products. Thus, through the Admin Core, INSPIRE Leadership will maximize generation of high-impact
knowledge about suicide prevention strategies designed to be rapidly deployable in a wide range of settings
serving the most vulnerable, and often disenfranchised, populations. The Core’s management strategy will
emphasize shared leadership, investigator support and mentoring, and intensive engagement of stakeholders
at every level (planning, evaluation, research, and dissemination) to maximize impact.